STRUCTURE OF A REPLICATIVE COMPLEX

The E. coli DNA polymerase III holoenzyme is a complex multisubunit enzyme that functions in natural in vitro multienzyme systems of DNA replication. Genetic and biochemical evidence have implicated the holoenzyme as being the polymerase responsible for the synthesis of the E. coli chromosome. Recent studies have led to a better understanding of the functions that give this enzyme its unique role in the replicative process. However, the lack of an understanding of the structure of this complex has hampered efforts to formulate detailed models for the holoenzyme-catalyzed reaction. Towards a solution to this problem, we propose to begin structural studies with the investigation proposed in this application. We plan to use the techniques of chemical crosslinking and fluorescence energy transfer to gain information concerning the arrangement of subunits within the replicative complex and the distance between important sites. Additionally, we propose to determine the position of the nucleic acid components within this complex. Structural tests of the dimeric replication hypothesis are also described.